The Center for Research, Health, and Social Justice

PROJECT SUMMARY – PROJECT 4
For decades, Black/African American people have had the highest cigarette smoking-attributable mortality in
the United States. Evidence-based interventions that could reduce the mortality burden have been slow to
reach Black smokers in the clinical setting. The long-term goal of this study is to increase provider advice to
quit smoking tobacco and patient referrals to lung cancer screening, evidence-based clinical interventions that
could have a powerful influence on saving the lives of Black people who smoke tobacco. To accomplish this
goal, the Black Health Block Quit and Screen Project will engage members of the National Medical
Association, the largest organization of Black health care providers in the United States, in a training and
education campaign guided by our novel and adapted version of the National Institutes of Minority Health and
Health Disparities Research Framework for Tobacco-Related Health Disparities. Our multidisciplinary team will
conduct a mixed-methods study (concept mapping and survey) in Phase 1 to better understand health care
providers' 1) knowledge, attitudes, and behaviors and 2) perceived political, social, and structural determinants
of health that impede Black smokers from quitting tobacco and screening for lung cancer. In Phase 2, our team
will use the data from concept mapping and the health care provider survey to develop training modules that
help health care providers deal with the unique needs of Black menthol smokers and people with social
disadvantage. Our study will examine the feasibility and impact of the Black Health Block Culturally Tailored
Training alone versus the Health Disparities and Lung Cancer Screening Training + the Black Health Block
Culturally Tailored training modules on changes in knowledge, attitudes, and behavior among health care
providers randomly assigned to each condition. In Phase 3, our team will examine the reach of the education
campaign that links patients and providers to resources to facilitate quitting smoking and lung cancer screening
via a patient navigator. The proposed study takes advantage of a unique and timely opportunity to prepare a
national organization of Black health care professionals to help Black smokers quit and screen amid pending
federal legislation to ban menthol cigarettes and flavors cigars. If this study is successful, then the data can be
used to launch a larger trial that tests the impact of culturally relevant training modules on health care provider
uptake of evidence-based clinical interventions and Black smokers' quitting and screening for lung cancer.
.

Public health relevance
NARRATIVE – PROJECT 4 The Center for Research, Health, and Social Justice (CRHS) uses a social justice framework to conduct research, engage communities, and build a diverse and competent research and practice workforce to reduce disparities in cancer and cardiovascular disease. The Black Health Block Quit and Screen Project seeks to engage Black health care providers in helping Black smokers quit tobacco use, including menthol cigarettes and flavored cigars, and screen for lung cancer early as strategies to reduce multiple chronic disease disparities.